Interdisciplinary Research Fellowship in NeuroAIDS

SUMMARY
The Interdisciplinary Research Fellowship in NeuroHIV (IRFN) is a two-year research education program
anchored on the premise that our future success in tackling the complexity of clinical problems in neuroHIV
depends on the availability of researchers with the training to imagine problem-solving approaches that cut-
across and integrate multiple relevant research disciplines. To this end, we have followed an interdisciplinary
and translational model of research training aimed at bridging the gaps left by single discipline approaches. Our
program functions as a neuroHIV-themed Special Institute emphasizing interdisciplinary and translational
research through immersion into the vibrant research setting of the HIV Neurobehavioral Research Program
(HNRP) and two main programmatic components: mentored research and focused didactics. Participants
receive close mentoring by experts in the field, leveraging the expertise of preclinical and clinically oriented
neuroHIV researchers. The IRFN outlines a clear progression toward independence in order to consolidate each
Fellow’s future success. Participants learn to approach neuroHIV research questions from an interdisciplinary
and translational perspective, with potential clinical applications as an essential end point of their work. In the
proposed renewal we will equally engage clinically trained as well as basic postdoctoral and early career
neuroscientists seeking to apply their talents to research on patient-oriented problems in neuroHIV. This serves
our translational goals by engendering “cross-pollination” of ideas. The research experiences of IRFN fellows
will be in the laboratories of high-caliber, nationally and internationally recognized neuroHIV researchers. Core
competencies will cover current thinking in NeuroHIV, from molecular to behavioral phenomena, general
research principles, research ethics, and grant writing skills. Essentials of good mentoring will also be taught
formally using evidence-based curricula. Additional didactics will center on professional development and
electives to enhance participants’ knowledge and individuation in areas of interest. Principles of equity, diversity,
and inclusion will be upheld across all components of the IRFN. Proposed for this renewal is the introduction of
seed funding for Fellows to conduct a focused, vetted pilot project in an area aligned with NIMH HIV research
priorities and the research themes within the HNRP, with the aim of facilitating a future extramural funding
application. The IRFN features: (1) outstanding faculty who have a long history of mentoring researchers to
become independent investigators, (2) individualized education, including research experiences that are tailored
to individual needs, (3) core and flexible didactic experiences, including lectures by leading neuroHIV
researchers, and (4) active evaluation and oversight of the program by a multidisciplinary advisory committee.

Public health relevance
NARRATIVE Complex clinical questions in neuroHIV require interdisciplinary and translational research approaches. The IRFN is a research education program that includes didactic experiences and close mentoring designed to augment the number of scientists equipped to tackle emerging challenges in neuroHIV.